Research Training in Gastroenterology

This is the renewal application for Years 11-15 of a training program designed to prepare scientists to
conduct state-of-the-art, multi-disciplinary research that will accelerate the translation of scientific
discoveries into actions that improve digestive health of people and populations and who will assume
leadership roles in digestive disease epidemiology and health services research. Trainees are at the
postdoctoral level: a mixture of MDs and PhDs supported for 2 years. The program places strong emphasis
on epidemiology and health services research, the rationale being the critical need for “bench to bedside”
translational research. There is also a need for “bedside to clinic”, or “efficacy to effectiveness, and patient
centered comparative effectiveness” translational or outcomes research. The mentors (3 MDs, 3 MD/MPH, 1
MD/MSHS, 2 MD/PhD and 3 PhDs) represent a multidisciplinary group of experienced investigators from
various departments at Baylor College of Medicine (BCM), all with well-funded research programs that cover
broad areas of clinical research including epidemiology (e.g., clinical, molecular, genetic, and microbiome),
health services research, decision making, and implementation research related to several digestive
disorders. Existing faculty members have outstanding mentoring histories, and excellent track records of
participation in our training program activities. The Program Director, Hashem B El-Serag, MD, MPH, will
continue on the grant, and Dr. Fasiha Kanwal, MD, MSHS will join as co-Director. They will jointly maintain
ultimate authority for the program and manage day-to-day operations. Together, they will coordinate
recruitment and selection of candidates, oversee the curriculum, and be responsible for the selection and
evaluation of the mentoring team. Major administrative decisions (e.g., selection of trainees) are handled by
the Training Advisory Committee, composed of the Program Director, co-Director, and three other program
faculty. Trainees have individual research mentoring committees, must prepare a written research proposal
to be defended to the committee, and have periodic reviews that include academic and career assessment.
Trainees attend and present at a weekly research seminar series and a monthly journal club. They are
selected from a highly competitive applicant pool that already exists at BCM. In the past 4 years, admission
to the program has been very competitive, and all available slots were filled with high quality candidates.
The trainees have performed well, with the two post-doctoral graduates obtaining master’s degrees in Public
Health, remaining in academia, publishing several first author original research papers in peer reviewed
journals and presenting at national research conferences. The current proposal includes new features
designed to enrich and enhance the existing program, including new mentors, the creation of two distinct
training tracks (epidemiology and health services research), and the expansion of enrichment activities,
such as team training, a monthly seminar on success in academic careers, and a wellness program.

Public health relevance
The education and training of young MD and PhD researchers is the lifeblood of continued progress in medical care. This training grant fills a critical need by preparing these individuals to work at the cutting edge of translational biomedical research in gastrointestinal and liver diseases. The training program focuses on mentoring, career development and advanced degrees in the methods of epidemiology and health services research applied to digestive disorders.